Training in Demography

DESCRIPTION (provided by applicant): The Population Studies and Training Center of Brown University requests continuing support for its T32 National Research Service Award. We request support for seven doctoral trainees and one postdoctoral trainee. In this application, we provide evidence of a strong multidisciplinary training program, supported by productive, committed faculty drawn from key social science disciplines and allied health fields. The PSTC training program proposed here builds on a dynamic research infrastructure, and we show evidence of major institutional support in the form of new PSTC physical space, significant investments in graduate education generally, and new faculty recruitment. In service of national and international public health needs, the PSTC training program recruits future leaders in the field into graduate study in sociology, economics, and anthropology. Trainees are grounded in their home disciplines and receive significant training in interdisciplinary population studies through coursework, mentored research activity, colloquia, workshops, student-led activities, and education in the responsible conduct of research. An active Training Committee will supervise these training paths, coordinating with our affiliated departments. We describe both continuing and innovative organizational and pedagogical efforts to secure the training goals we outline in this application. Substantive training is organized around key thematic areas that cover conventional demographic topics and expand into newly emerging areas. We demonstrate a high level of professional engagement among students in training and consequent impact on the profession after graduation. Our proposed postdoctoral program builds on a long history of such training (without prior support under this mechanism) and takes advantage of the same superior scholarly environment and interdisciplinary atmosphere. The postdoctoral program is built around individually tailored mentored training and research. We argue that the PSTC T32 training program shows ample evidence of continued intellectual and organizational evolution, dynamic synergy across disciplines and career stage, from new trainee through senior scholar, and a commitment to excellence that will produce and strengthen the next generation of investigators and teachers.